Core-008

The Innovation Ecosystem (Partnering for Innovation Value Optimization and Accelerated Translation [PIVOT]) program will embrace innovation and commercial translation to advance biomedical discoveries into the marketplace. Through this Optional Function of the CCTSI, we will develop and sustain an innovation program to educate, train and develop our workforce in commercial value translation; to support the technical development of commercializable innovation; and to demonstrate value and health impact of clinical and translational science innovation by providing access to accelerator venture capital funding, domain expertise, and commercialization mentorship. The overall goal of PIVOT is to provide a seamless, multi-level investigatorfacing infrastructure supporting the commercialization and product development of innovative ideas and, in the process, support and academically reward entrepreneurship. We will achieve these goals through the following specific aims: Aim 1: Workforce. Catalyze an academic entrepreneur culture and workforce by (a) disseminating and expanding the reach of bio-entrepreneurship training opportunities, (b) fostering entrepreneurial networking, and (c) demonstrating career trajectories for faculty and graduate students who are clinical and translational science innovators. Aim 2: Development. Accelerate the development of commercializable innovation through customer discovery by Innovation-Corps (I-Corps?) teams and promote combined usage of I-Corps and Team Science training for innovation teams receiving CCTSI pilot awards. Aim 3: Demonstrate impact. Accelerate health impact demonstration through active navigation to resources within the CCTSI ecosystem which provide commercialization mentorship, domain expertise, and accelerator funding. The CCTSI PIVOT program will serve as an integrator-navigator and resource multiplier to expand and extend the reach of entrepreneurial investment and infrastructure support provided by University of Colorado and Colorado State University and the Colorado Office of Economic Development and International Trade. PIVOT will also capitalize on two unique NIH workforce training programs in Colorado: the Broadening Experiences in Scientific Training (BEST) award for graduate trainees in clinical and translational sciences; and the I-Corps? Train-the-Trainer program at NCATS to develop a scalable short-course curriculum and common metrics adapted to the needs of clinical and translational science programs that will be disseminated across the CTSA consortium. In collaboration with an extensive network of state-wide, national and institutional innovation and entrepreneurship partnerships, PIVOT will lead a major academic shift within the CCTSI ecosystem by embracing innovation and commercial translation to advance biomedical discoveries into the marketplace. We will foster a culture that supports startup incubation and provides education and practical training to help academic ventures develop commercially-viable products and services.